Novel Bioresorbable Vascular Scaffolds with Uniform Biodegradation

Summary
Artery disease, such as atherosclerosis characterized by a build-up of plaque on arterial walls, so detrimental to the
continuity of blood flow, is of great societal interest due to its drastic impact on health in industrialized nations, where
obesity rates are high. While invasive procedures are not desirable, they are often crucial to ensuring patient survival. The
5 million coronary stents administered world-wide each year remain present in the human artery for the lifetime of the
patient. This has resulted in the emergence of several serious side effects. A bioresorbable metal stent that harmlessly
erodes away over time could minimize the normal chronic risks associated with permanent stents.
Stents made of bioresorbable materials are corroded and absorbed by the body after completing their task as vascular
scaffolding, allowing the stented arteries to restore their normal function. The concept may be achieved by engineering
stents that retain mechanical properties and integrity for at least 4 - 6 months before being broken down, metabolized, and
harmlessly excreted by the body, leaving the administrated vessel with a healthy endothelium, normal vasomotion and
free of implant. Therefore, the use of bioresorbable stents breaks the long paradigm of inert implants and opens a unique
opportunity for a second stenting procedure in already scaffolded segments of the blood vessels. Further, coarctation of
the aorta occurs in 3-4 in 10,000 births and accounts for 5 to 10 percent of all congenital heart defects. The stented vessel
is unable to grow with the child, leading to restenosis. Therefore, in infants and children, once the bioresorbable stent
disappears, the vessel is able to naturally grow until adulthood, avoiding repeated surgeries for serial stent dilatation.
Zinc (Zn) alloys are superior to currently accepted biodegradable polymers, magnesium and iron materials, with a near-
ideal corrosion rate and acceptable biocompatibility. The research in the last few years proves that minor alloying
additions to enhance both the strength by 2.5-3 times and corrosion uniformity paves the way to a fully bioresorbable Zn-
based stent. Additionally, the elastic ranges (elastic range = elastic modulus/ultimate tensile strength) for the formulated
Zn alloys are 0.19 - 0.27%. This is an important material parameter that describes the extent of elastic recoil following
stent deployment. These Zn alloys elastic range values are on par with 316L stainless steel (~0.17%) and L605 cobalt-
chromium alloys (0.16−0.32%) and are superior to Ti-6Al-4V and Ti-Mo alloys (0.72−0.85%) currently used for
manufacturing permanent stents. To validate the very promising Zn alloys for bioresorbable stent applications, the
proposed research program will conduct in vivo testing in the abdominal aorta lumen of ApoE -/- transgenic atherogenic
mice to evaluate their degradation behavior, thickness and make-up of neointima, and toxicity in an atherogenic
environment. Then, using the top biocompatible alloys, researchers will design, prototype, and test braided scaffolds
based on the following criteria: ease of deliverability, a high expansion ratio, improved mechanical integrity, uniform
corrosion, and desirable service time.

Public health relevance
Narrative Metal stents are commonly used to keep blood vessels open, but permanent stents can cause long-term complications. Bioabsorbable metal stents that harmlessly erode away over time may minimize the normal chronic risks associated with permanent stents. To develop such stents, new zinc-based alloys were developed and will be used to prototype and test novel braided scaffolds with a uniform biodegradation in physiological fluids.